CORE FUNCTION ACTIVITIES TASK ORDER TO PROVIDE EXPERT PI PROTOCOL REVIEWS, AD-HOC CONSULTATION, QUERY RESOLUTION AND OVERALL SITE-SPECIFIC MANAGEMENT AND PREPAREDNESS TO CONDUCT NEW STUDIES UNDER THE

The purpose of this Task Order entitled “Core Function Activities” is to provide needed expert PI protocol reviews in developing new clinical studies under the Network, ad-hoc consultation as issues arise pertaining Alcohol Use Disorder research inclusive of human safety issues, query resolution for studies conducted under the NIAAA Clinical Sites Network, and maintaining IT security preparedness and overall site-specific management and administrative reporting for activity conducted under the NIAAA Clinical Sites Network for Medications Development to Treat Alcohol Use Disorder.